ETHANOL AND FETAL GROWTH--ROLE OF THE PLACENTA

Intrauterine growth retardation and diminished brain growth with mental retardation are hallmarks of fetal alcohol syndrome. While ethanol may be directly toxic to the fetus, it may also be placento-toxic. The placenta is critical to normal fetal growth and development. Ethanol-induced placental toxicity would restrict the fetal supply of essential nutrients, thereby contributing to the pathophysiology of alcohol related fetal injury. We postulate that: (1) ethanol interferes with hormone-stimulated placental amino acid uptake, (2) in drinking women, chronic alcohol use impairs both hormone-stimulated and non-stimulated placental amino acid transport; (3) ethanol-induced inhibition of amino acid uptake in the human placenta results from decreased cAMP production and/or enhanced protein kinase C activity. Utilizing cultured human trophoblasts, the effect of ethanol exposure duration and dose on hormone-stimulated amino acid uptake will be evaluated. In addition, changes in hormone-stimulated uptake kinetics, hormone-receptor interaction, Na+, K+-ATPase activity and Na+/H+ exchange will be assessed in cultured trophoblasts and membrane vesicles prepared from the placentae of women who have ingested ethanol throughout pregnancy, but did not smoke. Hormone-stimulated and non-stimulated amino acid uptake will be measured. The third objective is to evaluate two potential mechanisms for ethanol effects on hormone-stimulated amino acid uptake: cAMP production and PKC translocation and activity. The results of the proposed studies should enhance our understanding of the role of ethanol-induced placental toxicity in the pathophysiology of ethanol- associated fetal injury.